Analytic Microscopy Core

PROJECT SUMMARY
ANALYTIC MICROSCOPY CORE
The overarching goal of the Analytic Microscopy Core (AMC) is to provide scientific and technical expertise in
optical microscopy applications that support of high-impact Member studies spanning all facets of cancer
research. AMC plays a vital role in the imaging pipeline from tailored study design to the development of novel
imaging techniques and the interpretation of resulting data in support of the Members. Further, AMC closely
collaborates with other Shared Resources to ensure proper and efficient handoffs of materials and image data.
AMC activities are organized into three Specific Aims:
Aim 1: To provide experimental design and implementation support for sophisticated microscopy-based studies.
Aim 2: To provide access to and assistance on advanced microscopy systems and image analysis platforms.
Aim 3: To train and educate Moffitt Members and their staff on the use of state-of-the-art microscopy and image
analysis platforms.
In support of these aims, AMC has collaborated with 112 Members (91% with peer reviewed funding) across all
five CCSG Programs (CBE 26%, CE 14%, MM 30%, HOB 2%, IO 28%), and has performed work on over 100
peer reviewed grants over the last reporting period. During this time, AMC has contributed to 115 publications
(25 high impact), which include discoveries in graft versus host disease, mouse melanoma models,
immunological features of ovarian cancer, and radiology/pathology correlations in breast tumors. AMC seeks to
address the growing needs of the Cancer Center by adding new services and equipment. Based on Member
input, during the past funding period new instruments for fluorescence and live cell microscopy were added to
increase capacity and provide new technologies. Further, AMC is pursuing other technologies, including high
content screening and multiplex fluorescence pathology imaging, to provide these new services to Members. As
part of its education programs, AMC provides several training sessions and presentations for existing equipment
and services, and also as hosts seminars and demonstrations for emerging microscopy related technology.
Future plans for the AMC include services that will provide 1) increased multiplex and whole slide fluorescence
imaging capabilities; and 2) high content analysis (HCA) microscopy for rapid, high-throughput, high content and
subcellular resolution imaging. Overall, AMC continues to support exceptional research of Moffitt Members by
providing cutting-edge microscopy equipment, services and education.